Imaging signatures of early tuberculosis

ABSTRACT
Early detection of tuberculosis (TB) disease to prevent transmission and disability is hampered
by the lack of precise biomarkers to diagnose and predict TB progression. The objective of this
study is to develop computational imaging tools to characterize and diagnose individuals
without TB symptoms who will progress to sputum culture-positive or symptomatic TB disease.
In Aim 1, we will combine computed tomography (CT) scans from existing and prospective TB
household contact studies to derive a high-resolution radiomic signature to predict and
characterize early disease pathology. In Aim 2, we will evaluate methods to enhance
performance of field-deployable chest-X-ray computer aided detection (CAD) systems to
diagnose early TB using transfer learning, image-to-image training, and integration of clinical
and epidemiologic variables. Our goal is to develop a fundamental toolbox for research,
diagnosis, and targeted preventive treatment of early TB to prevent transmission and
accelerate TB control.

Public health relevance
PROJECT NARRATIVE Detecting and treating tuberculosis (TB) before it becomes infectious or leads to disability is critical to TB control. We propose to use artificial intelligence combined with digital chest imaging (computed tomography and chest-X-rays) to develop a high-precision imaging toolset to characterize and diagnose early TB disease.